Receptor-mediated glucose sensing in yeast

ABSTRACT
This supplement grant seeks to address critical equipment limitations hindering our research on
receptor-mediated glucose sensing in yeast, which is essential for understanding cellular energy
balance and its implications for metabolic diseases like diabetes and obesity. To advance our
study, we request funding for four key pieces of equipment: a Fluorescent Microscope to enable
real-time visualization of glucose receptor dynamics in live yeast cells, allowing us to track
receptor behavior in response to varying glucose levels; a Multimode Microplate Reader to
facilitate high-throughput quantification of glucose uptake using the fluorescent glucose
analogue 2-NDBG, enabling efficient analysis across various experimental conditions; Protein
Extraction Equipment, including a cell homogenizer, ultracentrifuge, chromatography
refrigerator, and water purification system, to enhance our ability to extract glucose receptors
and transporters from yeast cell membranes for detailed biochemical analysis; and a qRT-PCR
System to improve gene expression analysis, allowing us to identify new signaling pathways
regulated by glucose receptors Rgt2 and Snf3. The acquisition of these tools will eliminate
critical research bottlenecks and significantly enhance our ability to investigate glucose sensing
mechanisms, driving the progress of our study and offering insights into the molecular basis of
metabolic diseases.
1

Public health relevance
PROJECT NARRATIVE We are seeking funding for essential tools to advance our research on how cells detect and respond to glucose, a key process in understanding diseases like diabetes and obesity. The equipment will allow us to observe glucose receptors in live cells, measure glucose uptake, study proteins involved in glucose sensing and analyze gene expression affected by these receptors. These tools will significantly enhance our research and deepen our understanding of receptor-mediated glucose sensing. 1